Methionine metabolism in the acute response to radiation in the gut

Abstract
This research project focuses on investigating potential radiomitigating strategies for gastrointestinal (GI) acute
radiation syndrome (GI-ARS), a severe condition resulting from high-dose ionizing radiation exposure to the GI
tract. GI-ARS is characterized by impaired cell division in intestinal crypts, inflammation, loss of intestinal
barrier integrity, and ultimately sepsis. Our study proposes two novel approaches to mitigate the effects of
radiation exposure on the GI tract. The first approach centers on methionine restriction (MR). Methionine, an
essential amino acid, plays a crucial role in normal tissue and tumor metabolic activity. It serves as a precursor
for S-adenosylmethionine, a key methyl donor in various cellular processes. Previous data suggest that
reducing dietary methionine improves intestinal barrier function and decreases inflammation. Preliminary
studies have shown that MR preserves crypt depth and villous height in the jejunum following acute abdominal
irradiation, indicating its potential as an intestinal radioprotector when initiated prior to irradiation. Aim 1 of the
project seeks to assess the mitigating effects of dietary MR on GI-ARS following radiation exposure. We will
use an animal model, employing total body irradiation, as well as partial body irradiation with 5% hindlimb
protection. Twenty-four hours post-irradiation, animals will either continue on a control diet or transition to a diet
with significantly reduced methionine content. We will evaluate survival rates after total and partial body
irradiation, as well as examine various tissue markers at 3.5 and 7 days post-irradiation. These markers
include crypt depth and villous height in the proximal jejunum, crypt survival, plasma citrulline levels, bacterial
16S RNA in the liver, and the expression of inflammation and tight junction genes in the proximal jejunum. The
second approach, outlined in Aim 2, investigates the potential of 3-Deazaneplanocin A (DZNep), an inhibitor of
methyltransferases, in mitigating GI-ARS. DZNep inhibits the enzyme S-adenosylhomocysteine hydrolase,
resulting in reduced methyltransferase activity, similar to the effect of MR. Previous studies have shown that
DZNep can decrease fibrosis, inflammation, and sepsis in animal models. Additionally, both MR and DZNep
activate the amino acid stress response pathway (ATF4) and decrease the methylation ratio in normal human
fibroblasts, suggesting a common mechanism of action. We will assess the mitigating effect of DZNep
administration starting 24 hours after irradiation, using the same experimental setup and endpoints as in Aim 1.
By exploring these two related but independent approaches, our project aims to identify effective strategies for
mitigating the severe effects of GI-ARS. The findings from this study could potentially lead to the development
of novel therapeutic interventions for radiation exposure, with implications for radiation emergency scenarios.

Public health relevance
Narrative This project investigates the potential of altering the metabolism of the amino acid methionine to treat civilians exposed to radiation. In Aim 1, the study will evaluate using a reduction of dietary methionine to improve gastrointestinal symptoms in an animal model following irradiation, evaluating survival rates and various tissue markers. Aim 2 will explore the radiomitigating effects of the administration of the methyltransferase inhibitor DZNep post-irradiation, using a similar experimental setup to Aim 1, to determine its potential as an alternative or complementary approach to dietary methionine restriction in treating GI-ARS.